Interoceptive Training Enhanced Mindfulness (ITEM): Acceptability and Measurement

PROJECT SUMMARY/ABSTRACT
Anxiety sensitivity (AS), which involves fear that arousal related symptoms will have negative physical, social
or psychological ramifications, is an important driver of anxiety, trauma-related and somatic disorders.
Cognitive behavioral therapy (CBT), particularly involving interoceptive exposure (IE; i.e., exposure to
unwanted internal sensations), has the greatest demonstrated efficacy at reducing AS but can be hard to
tolerate. Conversely, mindfulness is sought out for management of multiple mental health problems, but the
observed clinical effects are often modest. A hybrid of these two approaches may capitalize on the strengths of
each approach. Mindfulness training (MT) may increase the tolerability of exposure, enhance compliance and
support extinction learning through increased engagement with the feared stimulus and heightened awareness
of the nonoccurrence of feared outcomes. The proposed project, therefore, will refine a novel hybrid
intervention, Interoceptive Training Enhanced Mindfulness (ITEM), which combines IE with MT, evaluate its
feasibility and acceptability, and develop a multimodal assessment battery for use in subsequent studies. To
this end, 12 Veterans with high AS will complete ITEM, providing quantitative and qualitative information about
their experience. A panel of experts will use that material to refine the intervention. Following the refinement
process, 48 Veterans will be randomized to receive ITEM or IE in six one-on-one sessions delivered via
telehealth. They will complete assessments before and after the 6-week intervention period. Outcomes related
to engagement and compliance with ITEM and IE will be the primary focus of the pilot randomized controlled
trial (RCT). Additionally, we will examine the novel assessment measures to establish an optimal methodology
for subsequent efficacy studies. Because multiple mental health (e.g., anxiety, posttraumatic stress disorder,
eating disorders and depression) and physical health (e.g., chronic pain, conditions related to toxic exposure)
problems are driven by maladaptive reactions to interoceptive cues, this intervention has the potential to
ultimately produce wide-spread mental and physical health benefits.

Public health relevance
PROJECT NARRATIVE Maladaptive responses to interoceptive cues underlie several mental and physical health conditions. We propose a novel integrative treatment, Interoceptive Training Enhanced Mindfulness (ITEM), that combines interoceptive exposure with mindfulness to optimize change in anxiety sensitivity, i.e., discomfort with fear- related physiological sensations. The project will involve iterative refinement of ITEM, evaluation of its feasibility and acceptability and development of a multi-modal assessment battery for future efficacy studies.